Epigenetic mechanisms enhancing transcriptional response to environmental heat stress

Project Summary
Living organisms have evolved a universal heat stress or heat shock (HS) response to mitigate the proteotoxic
effects of a rise in environmental temperatures. For all eukaryotes, the master regulator of the HS response is
the highly conserved, homo-trimeric heat shock transcription factor (HSF1) which activate transcription of the
gene family encoding HS proteins (HSPs), molecular chaperones assisting protein folding. Although
transactivation by stress-regulated HSF1 is well understood, earlier events in the HSF1 path to transcription
remain unclear. This proposal tests the hypothesis that the chromatin architecture of HS promoters is pre-set by
distinct TFs such as NFY and SP1 collaborating with ATP-driven chromatin remodelers to establish and maintain,
or to ‘pioneer’ open chromatin, thereby enhancing HSF1 binding and enabling a temporally efficient response to
the environmental temperature stress. The proposed study applies the emergent technology of live-cell single-
molecule tracking (SMT) to directly image endogenous, tagged NFY and SP1 in living cells, allowing
quantification of diffusion kinetics at high spatiotemporal resolution and in vivo temporal occupancy as an
important Pioneering TF (PTF) parameter and development of new biochemical assays for nucleosome
displacement that distinguish between conceptually distinct mechanisms for generating chromatin accessibility.
These biochemical assays will provide mechanistic insights on how PTFs and chromatin remodelers collaborate,
informing the process by which HS gene chromatin is pre-set to accelerate HSF1 binding to chromatin, and are
generally applicable to assess the pioneering potential of other TFs expressed constitutively or are inducible by
environmental agents.

Public health relevance
Project Narrative To improve understanding of the epigenetic mechanisms by which the transcriptional response to environmental heat stress is efficiently managed, the project aims to discover fundamental principles under which chromatin architecture of heat stress-responsive genes is pre-set to enable a timely cellular reaction to thermally challenging conditions. This knowledge may stimulate new approaches to intervention that allow living organisms to better adapt to changes in environmental temperature. Beyond the heat stress response, development of new biochemical assays for the priming of chromatin organization for transcription should have broad applicability to understanding epigenetic mechanisms that regulate the transcriptional response to other environmental agents.